11th International Brain-Computer Interface Meeting

Brain-computer interfaces (BCIs) have the potential to restore communication and motor function to people
severely paralyzed from neurologic disorders. Rapid progress has been made over the past few years
particularly with the ability to restore speech and communication with BCIs with performance approaching
native typing and speaking rates. BCIs are being used in home environments more often than ever with
increasing performance stability. Additionally, there is increasing investment from industry to bring this
technology to market. Continued advances and successful translation of BCI technology into the clinic depends
on close and productive interactions that bring all stakeholders together to focus on critical scientific and
technical issues guided by user priorities. The International BCI Meeting Series, which has included 10
meetings since 1999, has always had the goal of bringing diverse disciplines together to discuss issues that
are critical for BCI development to restore communication and mobility. The BCI Meetings are instrumental in
creating the productive interactions and collaborations that are essential for continued progress. The BCI
Meeting will be organized to achieve the following specific aims:
1) Convene and foster productive interactions among all the disciplines and stakeholders whose
cooperation is crucial to successful BCI research and development. No other venue brings them all
together.
2) Present a concise and comprehensive update of the current state of BCI research and development.
3) Address topics critical for continued progress in BCI research and development through focused
workshops and targeted plenary sessions. Broader topics will be covered in oral and poster
presentations.
4) Promote the education and development of new researchers through the participation of many
graduate students and postdoctoral fellows. Networking events will encourage interactions between
new and established researchers and particularly target underrepresented groups of researchers.
5) Maximize the immediate and long-term meeting impact through publication of a special issue of peer-
reviewed primary articles and focused reviews derived from the meeting. Open-access conference
proceedings will inform both the scientific community and the general public.
In summary, the 11th International BCI Meeting will bring together a diverse BCI community, review the
present state of the field including recent advances, address key issues critical for translating research into
clinical use, and promote the education and mentoring of young researchers. Thus, like its predecessors, this
meeting and the resulting comprehensive publications will promote the continued development of BCIs that
can restore communication and motor function to people with paralysis or impairment.

Public health relevance
The International Brain-Computer Interface (BCI) Meeting Series is unique in providing an interdisciplinary, collaborative environment that convenes representatives from all fields involved in BCI research, including scientists, engineers, clinicians, policymakers, and users. The 2025 BCI Meeting will highlight innovative approaches and applications for BCIs, discuss progress towards translation, address key issues critical to further progress, and promote the education and participation of young researchers. This meeting and the resulting comprehensive publications will, like its predecessors, foster the translation of BCIs into clinically- viable devices.